Fatigue, Anhedonia and Cardiac Prognostic Markers in Depressed Patients with Coronary Heart Disease

Depression is associated with an increased risk of cardiac morbidity and mortality in coronary heart disease
(CHD). Although safe and modestly effective treatments for major depression exist, only about 30% of patients
ever achieve full remission. CHD patients with depression symptoms that do not respond to treatment are at
high risk for cardiac morbidity and mortality compared to those whose depression symptoms respond to
treatment. Anhedonia and fatigue are among the most common symptoms to remain following treatment in
both depressed CHD patients and in medically well psychiatric patients. In a recent study, we found that
several risk markers of cardiovascular morbidity and mortality including a high normal level of the thyroid
hormone free thyroxine (FT4), low nocturnal heart rate variability, blunted circadian heart rate, and poor sleep
quality predict depression treatment response and post-treatment symptoms of fatigue and anhedonia. It is
unclear why these risk markers are associated with residual anhedonia and fatigue. Elevated cortisol levels,
chronic sympathetic nervous system activation, reduced vagal modulation of HR, high levels of perceived
stress, low level of physical activity, disordered sleep, and occult subclinical thyroid diseases are among the
most plausible explanations. Any or all of these factors may explain the relationship between the risk markers
and residual fatigue and anhedonia, and all are potentially modifiable and thus possible targets for future
clinical trials. The purpose of the proposed research is to identify modifiable correlates of these risk markers
and of fatigue and anhedonia in depressed patients with CHD. Study participants will be recruited from
cardiology practices at Washington University School of Medicine. Potentially eligible patients will be
scheduled for a structured clinical interview. Those who score >14 on the BDI-II and meet the DSM-5 criteria
for major depression and no exclusion criteria will be enrolled. Participants will be evaluated at the Behavioral
Medicine Center at Washington University School of Medicine. The evaluation will be performed in the
morning after a 12-hour fast, and will start with a blood draw to obtain a thyroid panel, lipid profile, plasma
cortisol, C-reactive protein, and other biomarkers. Participants will be fitted with an ambulatory ECG monitor
and a wrist actigraph, complete a battery of self-report inventories, and be given instructions for collecting
saliva samples at home for cortisol measurement. The ECG monitor and actigraph will be worn for 48 hours
on two consecutive weekdays to measure the ECG markers, activity levels, and sleep parameters. Saliva
samples will be obtained three times per day for two days: upon awakening, mid-afternoon, and before
bedtime. Participants will be compensated for their time upon return of the samples and equipment. This study
will identify potential targets for adjunctive interventions to augment traditional depression treatments and
thereby help to lay the groundwork for a randomized clinical trial to determine whether treating depression in
patients with CHD can improve both depression and event-free survival.

Public health relevance
Project Narrative Depression doubles the risk of death in patients with coronary heart disease (CHD), but so far, there is insufficient evidence that we can reduce the risk of death by treating depression. This study will investigate the cardiac risk markers that are associated with depression symptoms that remain despite treatment, and identify potential targets for their treatment. The results of the study will inform the development of more effective interventions to improve both depression and survival in patients with CHD.